NC Collaborative HIV Epidemiology and Prevention (NC-CHEP) SWG

PROJECT SUMMARY/ABSTRACT – NC-CHEP SWG
Despite a robust toolkit of prevention and treatment options, HIV incidence in the US stubbornly remains around
39,000 cases per year. The reasons for this sustained, endemic spread of HIV are complex and interconnected,
making it an inherently challenging area of scholarship whose success depends on team science,
interdisciplinary approaches. It is precisely this kind of dynamic research environment that CFAR Scientific
Working Groups (SWGs) are designed for, and the UNC CFAR will promote research supporting Ending the HIV
Epidemic efforts through its North Carolina (NC) Collaborative HIV Epidemiology and Prevention (CHEP) SWG.
This team builds upon the long-standing partnership between UNC CFAR consortium partners and the NC
Department of Health and Human Services (DHHS), applying epidemiological data at the intersection of
biomedical and social sciences.
The NC-CHEP SWG will bring together experts across disciplines and investigators new to HIV to share ideas
and approaches, with the goal of fostering an academic environment conducive to thinking “outside the box.”
Under a conceptual framework acknowledging the interconnected social, ecological, and clinical realities of HIV
prevention and care, the NC-CHEP SWG aims to: (1) develop and refine resources for characterizing and
exploring the HIV prevention and care continuum; (2) sponsor and support activities to bring together intra- and
extramural expertise on basic, social, implementation, and prevention science to share perspectives and develop
research ideas; and (3) identify, recruit, and mentor new and early career HIV investigators, highlighting the
unique intersections among social science, basic science, and medicine within the HIV field.
To achieve these aims, the NC-CHEP SWG will: (1) update and curate a SWG membership directory and place
it online; (2) meet with NC DHHS personnel to understand available data, any interval changes, and how to
continue successfully working with NC DHHS data scientists and epidemiologists for data sharing; (3) work with
the Clinical Core to expand the number of HIV-uninfected, at-risk individuals represented in the UNC CFAR HIV
Clinical Cohort database; (4) initiate and direct work to characterize the prevention and care continuum in the
context of the COVID-19 pandemic; (5) offer consistent, regularly scheduled programming with physical and
virtual options to help members stay abreast of the “state of the science” in treatment and biomedical HIV
prevention; (6) promote high-quality research ideas based on team science approaches through face-to-face
and digital (asynchronous) peer review; (7) work with key faculty at UNC and our partners at historically Black
colleges and universities to promote HIV science as a career path; and (8) increase the reach of the SWG
members for disseminating their research by partnering with the state’s AIDS Education and Training Center to
host webinars, work-in-progress talks, and virtual symposia.